Examination of Health Disparities in ICU Delirium Prevention and Management for Patients Who Speak A Language Other Than English

The purpose of this Ruth L. Kirschstein National Research Service Award (NRSA) Individual Pre-Doctoral
Fellowship in Nursing Research (F31) application is to provide research training for Ms. Ahrens, a third-year
doctoral student at the University of Washington School of Nursing. The long-term goal of this training is for
Ms. Ahrens to develop into an influential independent researcher in a research-intensive academic setting with
a research focus on improving Intensive Care Unit (ICU) delirium prevention and management for patients who
speak a language other than English (LOE) to improve health equity for LOE patients in critical care. ICU
delirium is a consequential sequela of critical illness that affects up to 70% of ICU patients and is associated
with increased length of stay, hospital costs, and risk of death. The primary preventative and mitigation
strategy for ICU delirium is the ABCDEF bundle, which includes: Assess and treat pain; Both spontaneous
awakening trial and breathing trial; Choice of sedation; Delirium assessment; Early mobility; and Family
engagement. Due to a language barrier, LOE critically ill patients may be at increased risk of not receiving full
ABCDEF bundle components, as four out of the six bundle components are reliant on effective communication
for task completion and accurate assessments. Previous literature finds that professional medical interpreters
are used less than 20% of the time when they are necessary in medical settings. Critically ill patients have
additional barriers to professional medical interpreter use, and additional tools to facilitate cross-language
communication are needed. The contributors to health disparities for LOE patients in ICU delirium care have
not been previously studied. To address this gap, the proposed study will use qualitative and mixed-methods
implementation science design to investigate determinants of fidelity to the ABCDEF bundle for LOE critically ill
patients, guided by the health equity implementation framework and the implementation fidelity framework. Aim
1 of the study will qualitatively assess the facilitators and barriers to ABCDEF bundle fidelity for LOE patients
from 32-48 key stakeholders in ICU delirium prevention, including healthcare workers who implement the
ABCDEF bundle in the ICU at the University of Washington Medical Center and LOE ICU survivors who
received ICU delirium prevention care. Aim 2 of the study will assess the feasibility, acceptability, and
appropriateness of the VidaTalkTM application as a method to enhance communication between healthcare
workers and linguistically diverse patients while performing ABCDEF bundle tasks. The findings from this study
and associated training will provide foundational knowledge to generate a program of independent research for
Ms. Ahrens with the goal of improving health equity for LOE patients in critical care.

Public health relevance
PROJECT NARRATIVE As a social determinant of health, language barriers put patients who speak a language other than English (LOE) at increased risk for worse health outcomes in critical care. Yet, there is a significant gap in the science regarding prevention of ICU delirium for LOE patients. The proposed study will address this gap by exploring facilitators and barriers to ICU delirium prevention care for LOE patients in the ICU by interviewing key stakeholders in ICU delirium prevention care. Findings from this study will contribute to developing interventions in ICU delirium prevention for linguistically diverse patients that will improve health equity for this population of underserved patients.